Transcriptional and functional identity of human T follicular helper cells across tissues

Project Summary/Abstract
T follicular helper cells (Tfh) are indispensable for the development of memory B cells and plasma cells,
facilitating protective antibody responses through a mechanism known as B cell help. The expression of
lineage-defining molecules like Bcl6 and CXCR5 enables Tfh cells to migrate to B cell zones of lymphoid
follicles, where they provide this essential support. However, examination of Tfh cells in humans is challenging
due to their obligate tissue localization. Additionally, T cells with Tfh-like functions, known as peripheral helper
T cells (Tph), have been identified in non-lymphoid tissues of mice where they mediate localized B cell
responses to provide protection against reinfection. In humans, studies of Tph cells have been limited to
samples isolated from autoimmune and chronic inflammatory conditions, where they are implicated in
pathology, and it is unclear whether these cells can also play protective roles in healthy mucosal sites in
humans. A systematic analysis of human Tfh cells across lymphoid and mucosal tissues is crucial for defining
how T cells influence tissue-specific humoral immunity during infection, autoimmunity, and vaccine responses.
In the proposed study, we will make use of our novel human tissue resource, from which we have unparalleled
access to multiple mucosal and lymphoid tissues from adult and pediatric organ donors. Preliminary analysis of
these samples reveals an enrichment of Tfh and Tfh-like populations across mucosal and lymphoid sites of
children, necessitating examination in early life to define these populations, their properties, and functionality
across different sites. In preliminary studies, we identified Tfh-like cells in the lung, which express certain
phenotypes of Tfh cells and produced IL-21 associated with Tfh functional responses. Lung Tfh-like cells also
express site-specific signatures including production of multiple effector cytokines while also sharing a set of
core genes with Tfh that are associated with B cell help. We hypothesize that human Tfh cells possess a set of
core features across diverse lymphoid and mucosal tissues, but exhibit functional adaptations specific to the
site in which they reside. We will address this hypothesis in two Aims: (1) Identify a core signature and site-
specific adaptations of Tfh cells across diverse human tissues, (2) Determine role of site-specific Tfh cell
functions in B cell differentiation. We will dissect the transcriptional mechanisms that specifically, or
synergistically, regulate Tfh differentiation, functionality and localization, while interrogating the molecular
machinery underlying functional responses for promoting B cell differentiation and antibody secreting cells by
Tfh cells isolated from different tissues. This innovative and exploratory study aims to elucidate the cellular and
molecular mechanisms behind the essential function of B cell help in various human tissue sites.
Understanding these mechanisms could pave the way for tissue targeted approaches that induce localized
immune responses after vaccination or dampen these responses in autoimmune conditions, all while
preserving the overall integrity of the immune system.

Public health relevance
PROJECT NARRATIVE T follicular helper (Tfh) cells are indispensable for B cell responses, and resultant vaccine efficacy. Defining how they develop, migrate, and function in different areas of the body is important for two reasons: (1) these data will provide mechanistic insights into how vaccines work, and conversely how responses are dysregulated in autoimmunity, and (2) understanding the site-specific properties of Tfh may pave the way for tissue targeted approaches that induce localized immune responses after vaccination or dampen these responses in autoimmune conditions, all while preserving the overall integrity of the immune system.